In Vitro Human Tissue-Engineered Blood Vessel Disease Model of Progeria

ABSTRACT
Hutchinson-Gilford Progeria Syndrome (HGPS) is a rare autosomal dominant disease of accelerated aging.
Patients present with vascular stiffening, vascular calcification, and fibrous atherosclerotic plaque formation
causing vessel occlusion, which causes death between 7 and 20 years of age due to heart attack or stroke.
The disease arises from a point mutation (c.1824C>T) that produces the alternately spliced and farnesylated
protein progerin that accumulates in the cell nucleus. Progerin alters gene expression, causing increased
oxidative stress, apoptosis, and altered mitochondrial function. Pathological analysis of arteries of HGPS
patients shows loss of medial vascular smooth muscle cells (SMCs) and progerin in the medial vascular SMCs,
adventitial fibroblasts, and endothelial cells (ECs). While several potential therapeutics have been developed,
progress is limited by the few HGPS individuals available to enroll in clinical trials. During the first award
period, we developed an arteriole-scale tissue engineered blood vessel (TEBV) model using ECs and SMCs
derived from induced pluripotent stem cells (iPSCs) obtained from individuals with HGPS. HGPS TEBVs
exhibit the pathology observed in the disease including progerin expression, loss of SMCs, and calcification.
HGPS ECs exhibit reduced expression of flow-mediated genes, are pro-inflammatory, and have reduced
NOS3 gene expression that prevents TEBV vasodilation. HGPS TEBVs show improved function in response
to the farnesyltransferase inhibitor Lonafarnib with or without the rapamycin analogue, Everolimus. In this
competing renewal, in collaboration with Dr. David Liu and Dr. Kan Cao we will evaluate the hypotheses that
(1) adenosine base editors (ABEs), precision genome editing tools that can directly correct the most common
genetic mutation in HGPS, eliminate progerin accumulation in HGPS vascular iPSC-derived ECs (viECs) and
SMCs (viSMCs), restoring normal function of individual cells and TEBVs; and (2) functional and genetic
changes observed in ABE-treated TEBVs are observed in an HGPS mouse model treated with ABEs. We will
examine the extent to which base editing of HGPS viECs and viSMCs restores function and gene expression
after biomechanical stimulation. We will evaluate TEBVs made with edited cells for vasoactivity, stiffness,
cellularity, EC function, progerin expression, and inflammation to establish if normal function is maintained over
5 weeks. To simulate in vivo conditions, we will perfuse HGPS TEBVs with adenovirus vectors containing
guide RNAs and ABEs. We will establish dosage, percent transduction, and measure virus penetration into
TEBVs to determine conditions needed to achieve effective correction of vascular pathology in HGPS. Using a
mouse G608 HGPS model, we will treat with conditions identified in TEBV studies and compare cellularity,
stiffness, and EC inflammation. Single cell RNA-Seq will be used to evaluate the impact of editing on the
vascular cells in the mouse vessels and TEBVs after ABE treatment. Results of this study will provide
important information to advance ABEs to clinical trials for HGPS and use of ABEs to correct genetic diseases.

Public health relevance
This project involves using engineered human blood vessels created with induced pluripotent stem cells as a model for disease processes and development of new therapies. Such an approach can be extremely useful for rare diseases for which developing new therapies is extremely challenging and the number of patients is insufficient for clinical trials. Specifically, we will attempt to cure a rare genetic disease using a novel gene editing approach.